DIURNAL VARIATION OF BACTERIURIA IN PTS ON CLEAN INTERMITTENT CATHETERIZATION

Patients with spinal cord injury and myelomeningocele comprise the largest group of patients who suffer from neuropathic voiding dysfunction. Improper emptying of the bladder associated with high voiding pressures and urinary residuals can result in recurrent urinary tract infections, urosepsis and deterioration of renal function. A better understandingof the daily diurnal variation of bacteriuria in these patients will lead to better understanind of the pathogenesis of urinary tract infections.